Clinical decision-support algorithms for interactive design of patient-specific breast molds

Breast reconstruction can help feminine-presenting individuals retain or regain quality of life by mitigating the
impacts of body image disruption due to appearance changes arising from mastectomy. Autologous
reconstruction is widely recognized as effective, with long term advantages over other techniques. However,
autologous reconstruction procedures are complex, lengthy operations requiring substantial skill and experience.
Moreover, a revision procedure is typically required to adequately restore the patient’s bodily form; in some
cases, multiple revisions are needed. Prior work investigated simple molds that merely copied the preoperative
shape and size of the patient's breasts, or a mirrored version of the contralateral breast in the case of unilateral
breast reconstruction. But many patients desire or require a different breast form after mastectomy and so simply
copying the preoperative ‘native’ breast form is inadequate. The proposed study would shift current clinical
practice paradigms by enabling patient-specific molds for patients whose reconstructive goals are not merely to
reproduce their preoperative breasts. Moreover, while a few proof-of-concept studies have demonstrated the
feasibility of using patient-specific molds to shape tissue into a breast form, a critical barrier to progress in the
field is that no one has rigorously evaluated their impact. In contrast, the proposed study includes a randomized
controlled clinical trial for evaluation. The goal of this study is to develop clinical decision-support
algorithms for designing patient-specific breast molds for tissue shaping. We hypothesize that autologous
reconstruction will be more efficient when performed with patient-specific molds designed using our clinical
decision-support algorithms. The proposed project is significant because it has the potential to improve the
efficiency of autologous breast reconstruction, an important component of breast cancer rehabilitation. The
investigators are a multi-disciplinary team bringing complementary expertise in biomedical informatics,
biostatistics, engineering technology, and reconstructive procedures. This innovative project seeks to overcome
the limitations of prior studies by developing clinical decision-support algorithms to enable design of patient-
specific molds that are suitable for patients whose reconstructive goals are more complex than reproducing their
preoperative appearance. Our approach entails developing clinical decision-support algorithms informed by our
experience in image perception, machine learning, image processing, and shape modeling, and conducting a
thorough evaluation in a randomized controlled clinical trial. Our team will benefit from the extensive resources
available in the Multidisciplinary Breast Reconstruction Research Program. After successful completion of this
study, we will pursue a path to clinical translation analogous to existing products and services, such as current
systems for designing patient-specific molds used in mandible reconstruction.

Public health relevance
Project Narrative Autologous breast reconstruction is an important part of breast cancer rehabilitation for many patients. Our goal is to increase the efficiency of autologous breast reconstruction by helping the surgeon design patient-specific molds for shaping tissue into an acceptable breast form.